Statistical and Data Coordinating Center for the ADVN

The purpose of the Atopic Dermatitis and Vaccinia Immunization Network (ADVN) Statistical and Data Coordinating Center is to perform statistical and data analysis, clinical coordination, regulatory activities, and development of a patient registry, all in support of the clinical and animal components of the ADVN